SUD Care Transitions

PROJECT SUMMARY
The proposed study focuses on comprehensively characterizing the pathways of care utilized by people who
obtain care for substance use disorder (SUD) and comparing the quality and effectiveness of these care
pathways. Many effective SUD care pathways are recommended for use in healthcare systems. However,
patients with SUD often report poor care experiences particularly regarding timely follow-up, provider and
general satisfaction ratings, and care communication. Because SUD care pathways involve transitions across
providers and venues of care, adequate treatment of SUD requires coordination across providers and settings
to ensure that unmet needs are addressed, and appropriate SUD care is delivered. Surprisingly little is known
about the real-world care pathways that people engage in once they are identified by a healthcare provider as
having SUD. We propose to leverage a large novel data source from Kaiser Permanente Washington, a large
integrated healthcare system in the northwestern United States. The dataset will include electronic healthcare
records, insurance claims, and self-reported measures of substance use and SUD symptoms. To identify care
pathways, we will apply continuous time, multi-state Markov modeling methods to empirically observe the
longitudinal course of SUD care transitions undertaken by patients over time; each “state” or occurrence of
care will be characterized by the intervention received (e.g., withdrawal management, psychotherapy,
medication treatment) and setting of care (e.g., emergency department, primary care, behavioral health).
Additional states and model parameters will be used to characterize SUD care quality, such as wait times
between visits for SUD, concordance with SUD quality measures, and premature treatment termination. To
compare the effectiveness of identified pathways, we will examine outcomes including overdose, mortality,
remission, and substance-related medical conditions. Finally, employing an exploratory quantitative ->
qualitative sampling design, we will purposively sample patients who engaged in the empirically derived
pathways and interview them to understand their care experiences; we will also observe and interview
healthcare providers to elucidate health system factors that facilitate or hinder their ability to link patients to
adequate SUD care. SPECIFIC AIMS are: (1) Apply multi-state Markov models to comprehensively
characterize care transitions across the full spectrum of SUD care among patients with SUD within a large
integrated health system, (2) Generate data-driven insights to improve care delivery for SUD using estimated
multi-state models, and (3) Observe and explore patient and provider experiences with care transitions across
common care pathways using qualitative research methods. IMPACT: Researchers and health care
constituents do not know how to optimize care for SUD in healthcare systems. This study will identify and
compare the quality and effectiveness of common pathways that patients take when they obtain treatment for
SUD and provide decision makers with information on how to better organize the delivery of SUD care.

Public health relevance
NARRATIVE Well-defined effective treatment pathways exist for substance use disorder, but most patients in the United States receive inadequate treatment. The proposed research will apply state-of-the art statistical modeling to comprehensively characterize substance use care, care transitions, and clinical outcomes. Study findings will provide data-driven insights to inform health system improvements to increase initiation, engagement, accessibility, and coordination of SUD care.